Super Chef: Family Fun in the Kitchen

PROJECT SUMMARY (1/2 page)
Few interventions targeting single food groups have demonstrated long-term health success. The Mediterranean
Diet dietary pattern has been associated with reduced risk of cardiovascular disease (CVD), a leading cause of
death in the US. Dietary behaviors established in childhood track into adulthood, suggesting that healthful dietary
behaviors should be established during childhood. Children living in low-income households are at greater risk
of CVD and generally have less healthful diets, indicating a need for interventions to help them adopt more
healthful dietary practices. Parents are the gatekeepers of the home food environment and influence children’s
dietary behaviors through parenting practices around food (i.e., modeling of eating behaviors, home availability).
Foods prepared and eaten at home have been associated with better diet quality. Cooking skills have been
associated with home meal preparation, and children enjoy cooking with their parents. Encouraging parents to
involve their child in home food preparation and using healthful food parenting practices may be an effective way
to help children adopt a healthful dietary pattern. However, to promote behavior change, interventions should be
convenient, enjoyable, and personally relevant. Since Internet use and access are prevalent, including among
families with lower incomes, the proposed research will build on our previous research with parent/child dyads
from low-income households to develop an online cooking education intervention that promotes the
Mediterranean dietary pattern and healthful food parenting practices. We will assess its feasibility, acceptability,
and preliminary efficacy with 44 parent/child dyads. The results of this study have the potential to enhance child
cardiovascular health and inform the design of digital interventions promoting sustainable dietary behaviors in
at-risk children.

Public health relevance
PROJECT NARRATIVE (limited to 2-3 sentences) Given the limited effectiveness of single food group-targeted interventions to enhance child nutrition, a key component of current and future health, innovative approaches are needed. Healthy dietary patterns are emerging as an important intervention target, and the Mediterranean Dietary pattern has been particularly effective at reducing cardiovascular disease risk factors, a leading cause of death in the US. Since parents are the gatekeepers of the home food environment and influence child intake through their food-related parenting practices, children enjoy cooking with their parents, and home food preparation is associated with more healthful dietary intake, we propose to develop and assess the feasibility, acceptability, and preliminary efficacy of an online cooking intervention for parent-child dyads living in low-income households that promotes the Mediterranean dietary pattern and healthful food-related parenting practices.